Leveraging virtual care strategies to improve access and treatment for individuals with alcohol use disorders

Project Summary/Abstract
Despite the efficacy of psychotherapies, ~90% of people with alcohol use disorder (AUD) do not
receive treatment for this chronic condition and there are notable disparities in care. Access to and involvement
in efficacious AUD care is even lower for women, Black/African American individuals, and people from other
under-represented groups. Novel virtual care approaches (telephone, video, portal therapies) conceptually
rooted in efficacious therapies [e.g., motivational interviewing (MI), cognitive behavioral therapy (CBT)] and
theory can potentially improve treatment accessibility and appeal and reduce stigma. Virtual approaches have
had limited use in AUD care, recently increasing in COVID-19 to provide ongoing care (telephone/video
therapy) for current patients in specialty clinics, while treatment initiation remains low. There is an untapped
potential for virtual approaches to engage individuals across health systems, who otherwise do not receive
treatment, but could benefit. Virtual strategies, including telephone and video sessions and patient portals, are
promising for reaching and engaging substance-using populations, including under-represented individuals,
within health systems. Using a portal messaging system and phone calls to virtually engage patients in AUD
treatment outside of clinics and in their preferred locations is an innovative treatment model that can potentially
be implemented in health systems, but must be tested to inform broader dissemination.
We will use a sequential, multiple assignment randomized trial (SMART) to identify critical adaptive
intervention (AI) strategies for a virtually-delivered AUD engagement and care model. Adults with AUD (50%
women, 25% Black/African American, 5% Latinx) will be randomized to a 1st stage strategy for drinking
reduction and AUD care engagement integrating referral for AUD care: 1) a single telephone MI session (T-
engage), or 2) 4-weeks of a MI-focused portal messaging (P-engage). At 4 weeks, non-responders will be
randomized to a 2nd stage strategy: 1) step up to a video 8-session MI-CBT for AUD (phone delivery as
needed), or 2) continued 1st stage (i.e., 4 weeks of P-engage with greater depth, a second T-engage session
building on the first). Outcomes will be assessed at 4-, 8-, and 12-months. Aim 1 will compare 1st-stage
strategies (T-engage vs. P-engage) on alcohol outcomes and AUD treatment utilization. In Aim 2, among 1st-
stage non-responders, we will identify the most efficacious 2nd-stage strategy. Aim 3 includes an
implementation planning phase, with cost measures, and key stakeholder interviews and qualitative analysis of
barriers and facilitators to implementation and adoption of a virtual care model. Secondary aims include:
examining the moderating effects of race/ethnicity and sex on outcomes given our enriched sample and
examining the best sequence of AIs. Our proposed project will have high public health impact by evaluating a
novel virtual care model focused on increasing both treatment engagement and delivery that can be integrated
in health systems to increase AUD treatment appeal and accessibility and help address treatment disparities.

Public health relevance
Project Narrative About 90% of people with alcohol use disorder (AUD) do not receive treatment, with even lower rates among women, Black/African American individuals, and people from other under-represented groups. Care for AUD has typically focused on referrals to specialty addiction treatment programs, which have barriers to accessibility and are stigmatized, thus not widely appealing. To address this gap, this project will use a sequential, multiple assignment randomized trial (SMART) design to examine a novel virtually-delivered engagement and treatment delivery model that can be integrated in healthcare systems to substantially improve utilization and outcomes and reduce disparities in care for this chronic condition.